Therapeutic strategies to rescue metabolic deficiencies in spinal and bulbar muscular atrophy

Project Summary:
Several neurodegenerative diseases, including Alzheimer’s disease, Parkinson’s disease, and the
polyglutamine expansion diseases, result from protein misfolding and accumulation due to genetic
and/or environmental causes. Spinal and bulbar muscular atrophy (SBMA) is an adult-onset, inherited
(X-linked) neuromuscular disease that is caused by polyglutamine expansion within the androgen
receptor (AR); it is related to other neurodegenerative diseases caused by polyglutamine expansion,
including Huntington’s disease and several spinocerebellar ataxias. Although the precise pathways
leading to neuronal dysfunction and death are unknown, the evaluation of mouse and cell models of
these diseases has yielded mechanistic insights into disease pathogenesis. SBMA stands apart from
other polyglutamine diseases in that its onset and progression are dependent on AR androgenic
ligands. Metabolomic analyses of muscle and spinal cord from two mouse models of SBMA revealed
severe reductions in muscle NAD+ while spinal cord showed no such changes. Treatment with
nicotinamide riboside (NR) to restore NAD+ levels was unsuccessful. However, RNA-seq studies
revealed substantially reduced levels of muscle NMRK2, which encodes an enzyme required to convert
NR to NAD+ in muscle, suggesting a likely reason for both the reduction in NAD+ and its intransigence
to NR treatment. We propose to bypass NRK2 through the systemic administration of nicotinamide
mononucleotide (NMN) to two mouse models of SBMA with distinct expression patterns of
polyglutamine-expanded androgen receptor but common defects in muscle NAD+ levels. The two
mouse models of SBMA used within this proposal reproduce the androgen- and polyglutamine-
dependent nuclear AR aggregation seen in patients, as well as its consequent toxicity, making studies
using these models relevant to human SBMA patients. The successful completion of this study will
reveal whether this simple therapeutic regimen could be beneficial for patients with SBMA.

Public health relevance
Public Health Relevance: Spinal and bulbar muscular atrophy (SBMA) is one of 9 polyglutamine diseases that are part of a larger family of neurodegenerative diseases characterized by protein misfolding and accumulation; these diseases include Alzheimer’s disease, Huntington’s disease, Parkinson’s disease and amyotrophic lateral sclerosis (ALS). Disruptions in the homeostasis of energy metabolism are observed in many of these diseases, including SBMA. We propose here to test the therapeutic potential of a molecule, nicotinamide mononucleotide, that bypasses a defective metabolic enzyme in skeletal muscle of SBMA mice and which is likely to restore one aspect of energy homeostasis in SBMA.